srvc-EHSR: Sysrev Version Control - Environmental and Health Related Systematic Reviews

Environmental & Health-Related Risk Assessments (EHRRA) are an integral part of new product
formulation, as well as product safety stewardship. Unfortunately, the current process for conducting EHRRAs
is expensive and slow. According to the EPA report: "FY 2021 Contributions to EPA's Portfolio of Evidence",
the cost of conducting a Toxic Substance Control Act (TSCA) Chemical Evaluation is approximately $8.4MM
over 3.5 years. Currently, most EHRRAs rely on the manual curation of data via Systematic Literature Review.
This process, while integral to the overall accuracy and completeness of EHRRAs, requires hundreds of
research hours. Therefore, academia, industry, and government regulators would all likewise benefit from a
platform which leverages machine learning to optimize EHRRA related literature and systematic reviews. More
specifically, there is currently a strong value proposition in the $534BB global cosmetic industry, $221BB global
agrochemical industry, $235BB global home cleaning supplies industry, and $1.5TT global consumer
packaged goods industry for tools that optimize SLRs for EHRRAs.
To minimize the amount of time required by SLRs for EHRRAs, advances in machine learning (ML) are
increasingly helping researchers more quickly identify relevant pieces of information. One major obstacle to the
development and use of additional ML tools for EHRRAs is integrating such tools into existing SLR platforms.
While an increasing number of these platforms utilize, or permit the utility of, ML models, their complex
codebase makes it too cumbersome to deploy new features or integrate ML tools for specific use cases. As a
result, risk assessments continue to rely on long, manual literature reviews which, in turn, delays accessibility
to new data to make informed chemical and product safety decisions.
The 'srvc-EHSR' platform will solve this growing market need though a git-based, remote-deployment
capable, application which enables EHRRA researchers to build customizable workflows based on
standardized, interchangeable SLR and ML components. The platform will prioritize internal and external
interoperability of components to ensure fit-for purpose adaptability. As a result, srvc-EHSR will enable more
efficient SLRs and more thorough EHRAAs, thereby decreasing the time-to-market for new products and
increasing the overall safety of consumer and industrial chemicals.
While the fully commercialized srvc-EHSR will integrate the features above, Phase I will target
feasibility for component modularity and interchangeability, ML development, and prototype interface.
Development will leverage existing assets, BioBricks.ai and Sysrev, to develop core Phase I srvc-EHSR
components as cost-efficiently as possible. A prototype cloud based application, terminal interface, software
“packages”, and API will be developed and deployed in a usability study by the Phase I Commercial Partner
wherein researchers will use srvc-EHSR to review documents for environmental, chemical, and health data.

Public health relevance
The Phase I objective is to design, develop, and demonstrate feasibility of srvc-EHSR ("Sysrev version control - environmental and health systematic reviews"), a modular, cloud-based, remote-installation-capable, platform which allows researchers to build customizable literature review workflows for environmental and health- related risk assessments. While several established platforms for systematic literature review exist, they lack interoperability, are not fit-for-purpose for risk assessment, and their complex codebase makes it too unwieldy to integrate new features to adapt systematic review methodologies for specific use-cases. Therefore, srvc- EHSR will increase the efficiency of literature reviews, make literature reviews more applicable to risk assessments, produce standardized data for research consumption, inform new and more powerful in silico models, decrease the scientific community's reliance on animal testing, and promote safe chemical use in consumer and industrial products and formulations.